The Development and Evaluation of Enhanced Digital-Chemosensory-Based Olfactory Training for Remote Management of Substance Use Disorders (EDITOR)

ABSTRACT
The Development and Evaluation of Enhanced Digital-Chemosensory-Based Olfactory Training for
Remote Management of Substance Use Disorders (EDITOR) is a project to develop a sustainable, scalable,
and patient-centered mobile health platform, comprised of (1) patient-facing culturally-adapted digital-
chemosensory therapeutic for stimulant, alcohol and opioid use disorders, sensors for acquisition of objective
physiological measures of substance intoxication and withdrawal, and application for running and interpreting
the interventions and sensory acquisition programs; and (2) a provider-facing web portal, for substance use
disorder treatment in socially-disadvantaged and sexual minority populations. Management of substance use
disorders (SUD) mostly involve direct contact between patients and providers, but the precedence of COVID-
19 pandemic has elevated the need for patient-centered remote management of SUD. While digital
therapeutics and mobile health platforms provide avenues for remote management, our communities of African
Americans (AA), Hispanic-Americans (HA) and other socially disadvantaged populations lag in adoption of
these mobile platforms, due to inability to read, digital illiteracy, lack of access to smartphones, absence of
reliable Wi-Fi or internet, and financial constraints. Moreover, while interventions exist for Opioid Use Disorders
(OUD), there are no drugs for cocaine or stimulant use disorders. Underserved AA and HA communities with
OUD, particularly marginalized men who have sex with men (MSM), have more severe co-existing cocaine,
methamphetamine, and alcohol use disorders; and digital solutions for these populations are lacking. Providers
on the other hand, lack well-adapted, intelligent-based physiological and psychophysical acquisition platforms
to guide remote agonist management of opioid and alcohol withdrawal. Through Phase I SBIR, EVON Medics
developed a combinatorial digital chemosensory-based orbitofrontal cortex training for Opioid Use Disorder
(CBOT). Based on the limitations of CBOT for our socially disadvantaged AA, HA and MSM population, we
recently revised the platform for treatment of stimulant and alcohol use disorder, by including beta-
caryophyllene chemosensory stimulation. We propose further product development, with innovative changes to
the patient-facing platform and a new provider-facing platform to guide remote management of OUD, Stimulant
(cocaine and methamphetamine) use and alcohol use disorders through Fast-Track SBIR funding. In Phase I,
we will configure the patient-facing platform with: voice commands, different languages especially for the non-
English speaking, non-Wi-Fi or internet-dependent connectivity solution, reliable pupillary, pulse rate and spo2
physiological acquisitions and psychological (e.g., craving) surveys; and the provider-facing component to
provide interpretation of patients’ data in a HIPAA-secure portal. We will do preliminary testing in 3 substance
use programs, Howard University emergency room, and community populations in the under-served Ward 8
communities in Washington, DC. In Phase II, we will perform a pilot randomized trial of EDITOR compared to
treatment as usual and CBOT for office-based treatment of SUDs in several federal funded programs
associated with Evon Medics and Howard University. Upon completion of Phases I and II, we will be poised to
expand the research to either a larger, Phase III efficacy study, or an implementation study of effectiveness in
the real-world setting through commercial partnerships developed over the course of this project. To the best of
our knowledge, this will be the first evaluation of Digital-Chemosensory-Based platform for remote
management of SUD, culturally adapted for socially disadvantaged communities and populations.

Public health relevance
NARRATIVE A comprehensive and fool-proof strategy document for participation in the I-Corps program by Evon Medics leadership team to leverage the mentorship opportunity and acquire first-hand feedback from industry experts, patients and payers in order to refine our product, the EDITOR to an acceptable and valuable product that will be used and payed for.